Training Program in Research Ethics in the Americas

1. Project Summary
This Training Program in Research Ethics in the Americas provides in-depth education
in ethics for researchers in biomedical and social science, members of research ethics
committees, and educators working in related fields. The program began as a
collaboration between Albert Einstein College of Medicine (USA) and the Facultad
Latinoamericana de Ciencias Sociales (FLACSO) in Buenos Aires, Argentina and is
now held in its entirety at FLACSO. The program addresses the current situation in the
region, selecting new trainees from areas where leaders in research ethics are needed.
At the same time, former trainees can participate in the activities of the current
program. The program for new trainees includes both practical and theoretical
educational activities, beginning with a three-month stay in Buenos Aires and continues
with online coursework that culminates in a master's degree. Among the experiential
learning activities, the program offers ongoing mentoring focused on writing skills and
critical thinking, as well as meetings with local scientists engaged in research. Trainees
have the opportunity to observe not only how research ethics committees and
community advisory boards function, but also attend the National Research Ethics
Advisory Committee's in-person meetings. The program includes mentoring plan for
former trainees who have completed the program with the aim to expand their
educational opportunities in the region and ensure sustainability.

Public health relevance
Project Narrative This program educates researchers and members of research ethics committees from Latin American countries and improves their expertise in research ethics, thereby increasing ethical capabilities in the conduct and review of research. It also provides continuing education in research ethics for former trainees to ensure ongoing sustainability of research ethics in the region.